Investigating Fall Mitigation Strategies when Walking with an Exoskeleton for Users with Lower-Limb Paralysis

Paralysis as a result of a spinal cord injury can severely impact activities of daily living, limit
independence, and negatively impact overall health of Veterans. Powered exoskeletons are an evolving
technology aiming to improve mobility and quality of life for individuals with paralysis. Clinical studies of users
walking with exoskeletons report a reduction in pain and spasticity and improvements to bone density and
muscle tone. Currently, commercial exoskeletons have FDA 510(k) clearances that require continuous contact
guarding or stand-by-assistance by a spotter. During instances of falling, these devices are only designed to enter
joint-locking configurations and require the user to balance themselves via crutches, a walker, or intervention from a
caregiver to prevent impact with the ground. The rationale of this CDA-1 is that the absence of safety features that
prevent falling while wearing an exoskeleton may be restricting the technology to monitored environments with
trained caregivers and be preventing their widespread use within the community. The purpose of this award is to
provide Dr. Hnat with the required training to become a successful researcher within the VA system and to lead
her towards achieving her long term goal of designing an exoskeleton that detects destabilizations and
prevents falls from occuring. The current proposal addresses the candidate’s short term goals regarding the
issue of falling with powered exoskeletons by exploring configurations to reduce the impact with the ground and the
potential of injury should a fall occur. The proposed work is immediately translatable into a hybrid neuroprosthesis
resulting from the primary mentor’s funded research (Dr. Ronald Triolo) and will serve as preliminary data for
subsequent CDA-2 and VA Merit Award proposals.
The project goals will be achieved through two Specific Aims. Specific Aim 1 includes a series of able-
bodied walking experiments while wearing an exoskeleton while experiencing a slip or trip on an instrumented
treadmill. A Fall Classification Algorithm (FCA) will predict the occurrence and classify the type of a fall
using center of mass kinematics measured from the experiments. Specific Aim 2 focuses on identifying the
exoskeletal configurations that minimize the magnitudes and locations of impact forces on the user and
applying this information to design an Impact Mitigation Controller (IMC) that reconfigures the exoskeleton’s
joint angles into these safer configurations. Optimizations of a 3D musculoskeletal model developed in the
OpenSim Modeling Suite will minimize the impact forces at the head, joints (neck, shoulder, elbow, wrist, hip,
knee, and ankle), and long bones. These experiments will be repeated on an instrumented crash-test dummy
and the potential for injury of the reconfigured positions will be statistically compared to the baselines. The
trained FCA and IMC will be validated in real-time in a repeated set of experiments with able-bodied
participants.
All studies will be performed at the Louis Stokes Cleveland VA Medical Center in facilities associated
with Advanced Platform Technology Center, such as the Motion Study Laboratory directed by Dr. Triolo. Dr.
Hnat has identified multiple training aims within her proposal, including developing musculoskeletal models and
performing optimizations with them, designing experiments that represent realistic falling scenarios, learning
and applying statistical analyses to collected data, practicing hardware design and implementation, and
understanding the challenges experienced by individuals with SCI. The mentoring team she has assembled is
well equipped to help the candidate achieve the training aims outlined within this proposal as well as transition
to a successful independent researcher in rehabilitative technologies.

Public health relevance
Individuals with paralysis represent a significant portion of the Veterans patient base. Paralysis reduces the ability to perform tasks of everyday living and can result in secondary health impacts (bone density loss and muscle atrophy) and a withdrawal from work and social activities. Powered exoskeletons are wearable robots that enable individuals with paralysis to walk again and exercise their paralyzed limbs. Although exoskeletons are safe for use in rehabilitative or home environments with trained caregivers, this CDA-1 proposal aims to explore falling with an exoskeleton and to reconfigure them into lower joint impact configurations to reduce potential injury to users if a fall should occur. Developing these features will amplify the health benefits of exoskeletons being prescribed for Veterans with paralysis by allowing more widespread and spontaneous use to encourage users to strengthen their muscles, improve their overall health, return to work, and become more actively engaged within their communities.